Targeting T3SA proteins as protective antigens against Yersinia

Summary
Yersinia pestis causes bubonic, septicemic and pneumonic plague with high rates of mortality in the
absence of immediate treatment. Although Y. pestis is susceptible to many antibiotics and outbreaks have
been contained in present day, plague continues to cause lethal human infections in areas where Y. pestis
has established persistent enzootic cycles in wild rodents. In 2015, 15 plague cases were reported in the
United States, several occurring in National Parks, with a case fatality rate of ~33%. This underscores the
challenges associated with combatting this devastating disease. Additionally, Y. pestis has been deployed as
a biological weapon and with its genetic tractability, natural acquisition of antibiotic resistance and relative
ease of acquisition from nature, Y. pestis has been classified as a weaponizable pathogen with the potential
for inflicting widespread human death. Yersinia spp. that are pathogenic for humans possess a type III
secretion system (T3SS) that is essential for virulence. This T3SS injects protein effectors into host cells to
manipulate functions for the benefit of the bacterium. The T3SS apparatus (T3SA) provides the energized
conduit for translocation of these effectors from the bacterium and into the host cell cytoplasm. The external
portions of the T3SA are the needle, the tip protein and the first of two translocator proteins. For Yersinia,
LcrV is the needle tip protein and YopB is the first translocator protein. These proteins are highly conserved
among Yersinia spp. and are required for pathogenesis. We have demonstrated that, when administered
intranasally (IN) in the presence of the appropriate adjuvant, these two proteins protect mice against a lethal
challenge by Y. pestis and Y. enterocolitica. We have fused LcrV and YopB to produce YerF and have fused
LTA1, the active moiety of dmLT (double mutant labile toxin) from enterotoxigenic E. coli, to the N-terminus
of these fusions to produce L-YerF. Within this proposal, we intend to assess the L-YerF as a self-
adjuvanting protective subunit vaccine. We hypothesize that L-YerF will provide humoral and cellular
immune responses that will protect mice against infections causing pneumonic and bubonic plague.

Public health relevance
Narrative Yersinia pestis causes plague with high rates of mortality in the absence of immediate treatment. The current vaccine has had inherent limitations surrounding production as well as immune response. We have developed a vaccine that targets conserved proteins with an adjuvant that elicits humoral and cell-mediated immune responses.